Core A - Administrative Core

ABSTRACT
The Administrartive Core provides leadership and scientific vision for the ADRC, ensures integration and
synergy across ADRC Cores, regulatory compliance with NIH and university policies, and timely submission of
data and biosamples to NACC, SCAN and NCRAD. The Core guides the scientific direction of the ADRC,
catalyzing clinical and basic research in Alzheimer’s Disease and Related Dementias and promoting National
Alzheimer’s Project Act milestones. The Administrative Core will develop and maintain the overarching
organizational and administrative structure for all the ADRC cores, Developmental Projects, and related
activities under the leadership of Director Gil Rabinovici and Associate Directors Katherine Possin and Howard
Rosen. The Administrative Core will drive and direct the internal integration across all cores, including the
Clinical Core, the Data Management and Statistical Core, the Neuropathology Core, the Outreach Education
and Engagement Core, the Neuroimaging Core, the Biomarker Core, the Research Education Component, and
the three Developmental Projects as they are implemented. Essential activities include promoting and
supporting new and ongoing collaborations critical to advancing research while introducing new trainees and
investigators to the field. The Administrative Core will carefully oversee and follow all applicable regulatory and
fiscal controls. The core serves as the primary liaison between the center and other entities that inform our
research and strategic planning process, including the faculty/staff, Executive, Internal and External Advisory
Committees and Community Advisory Boards. The Administrative Core will work locally to garner institutional
resources while stimulating collaborations across UCSF. A major effort is focused on maintaining an active and
productive engagement with community partners and both national and international collaborators. Key
operational functions include providing communication tools and efficient services for fostering innovative
research, training, reviewing and fulfilling data and resource requests, implementing the ADRC data sharing
plan and policies, coordinating progress, disseminating knowledge, fiscal management, and reporting. The
administrative team will guide strategic planning, program monitoring and evaluations, and responsive
improvements.